2024 Bones and Teeth Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY:
The skeleton is a dynamic, mineralized organ composed of many tissues with a variety of vital functions. Over
the past few years, powerful new approaches have revealed unexpected complexities regarding the sources and
differentiation of cells that create and maintain the skeleton but have also opened exciting avenues of research.
These areas of investigation may lead to novel treatments for devastating conditions such as osteoporosis,
osteopetrosis, bone cancer, and genetic disorders of the skeleton. The goal of the 2024 Bones & Teeth Gordon
Research Conference (B&T GRC) is to bring together investigators and trainees focused on a variety of areas
in skeletal research to discuss and evaluate the latest findings. A broad range of areas will be highlighted,
including identification of stem and progenitor cells that participate in mineralized tissue development,
maintenance, and disease. We will also discuss recent advances in rare diseases that affect the skeleton, how
bones and teeth respond to mechanical loads, and how cells in these tissues communicate under physiological
and pathological conditions. Our program will include a diverse set of speakers from all career stages. As in the
past, this conference will prioritize participation of trainees and promote their interaction with established leaders
in the field with the goal of building productive and lasting collaborations. Based on the successful Gordon
Research Seminar (GRS) that preceded the B&T GRCs in previous years, the GRC organization has approved
a GRS associated with the 2024 B&T GRC. The 2024 B&T GRS, organized by Carolyn Chlebek and Tim
Herpelinck, will be called "Revolutionizing Skeletal Biology: New Horizons and Technological Advances". The
meeting will highlight emerging technologies that have significantly advanced skeletal biology research. GRS
will also feature a mentorship program that provides guidance to early-stage scientists on career development.
This year, the mentorship component will be called “A Guide to Impactful Research”. Selected mentors will form
a panel focused on research impact ranging from academic excellence, translational potential and valorization
to scientific outreach. The organizers will select talks from submitted abstracts, and all attendees are encouraged
to present posters and stay for the subsequent GRC. Based on previous experiences, young scientists are
excited by GRS participation and remain highly engaged at the GRC.

Public health relevance
PROJECT NARRATIVE: The skeleton is an organ with numerous vital functions. The 2024 Bones and Teeth Gordon Research Conference and Seminar will discuss major new discoveries regarding the skeleton and its functions. These new and exciting discoveries may lead to novel treatments for devastating diseases including osteoporosis, bone cancer, genetic disorders of the skeleton, and skeletal problems associated with diabetes.